Human Cortical Ripples as a Mechanism for Neural Binding

PROJECT SUMMARY
‘Binding’ refers to the process whereby elements encoded by multiple brain areas are integrated into a coherent
whole during perception, cognition, and action. The elements may be perceptual (such as the color, shape,
location, motion, and texture of a visual object), but they may also include executive function and the integration
of meaning, instructions, and movements. Disruption in cortical neural binding may also be implicated in the
pathophysiology of many forms of neuropsychiatric disease, however, the mechanisms by which highly diverse
neural information is integrated in the human cortex are largely unknown. Current explanations often rely on
hierarchical multimodal convergence, or on synchronized high frequency oscillations, but these remain largely
untested in the human brain.
Several properties of recently observed human cortical ripples are consistent with ‘binding-by-synchrony’,
including their broad anatomical and behavioral distribution, phase-modulation of local firing, and especially their
co-occurrence and phase-locking between widely separated locations. Thus far, our group and others have
demonstrated that co-rippling is enhanced during memory recall in waking, and in NREM sleep, possibly
associated with memory consolidation.
The proposed study will test if cortical ripples possess other properties crucial to a possible role in binding. Aim
1 will test if cortical neurons in different areas interact more strongly when their locations engage in co-occurring
ripples by recording populations of single neurons in different segments of the cortex during spontaneous
behavior using established microelectrode technologies. Aim 2 asks if cortical rippling and co-rippling occur in
behavioral contexts that elicit binding beyond memory recall during waking, and consolidation during NREM.
To achieve these aims, this proposal includes the acquisition of novel human intracranial recording data and the
analysis of a large collection of human electrophysiology data that has grown over the last decade. This unique
dataset includes multi-hour and multi-day continuous recordings of local field potentials and single neuron firing
in multiple cortical areas in humans, using two patient groups and several micro-arrays. Together, these aims
will test if widespread co-occurring and phase-locked cortical ripples may serve as a substrate for one of the
foundational functions of the human brain: to bind disparate content into a unified experience. Ultimately,
illuminating the interactions between neurons during cortical ripples may be critical for understanding the
temporal organization of neuronal network activity, and may provide the foundation to help better understand
human cognitive disfunction.

Public health relevance
PROJECT NARRATIVE The Binding Problem asks how the diverse contents of awareness are unified, a cortical process that is fundamental to understanding healthy and disrupted cognition in humans. This study will test if bursts of high- frequency cortical oscillations (i.e., ‘ripples’) possess the properties crucial to a possible role in binding. If successful, this work will lay the foundation to study neural binding in the human cortex, thereby facilitating the investigation of how information processing is disrupted in many form of neuropsychiatric disease.